Integrated Membrane Program (IMP)

Project Summary
The Integrated Membrane Program (IMP) T32 Training Grant will address an important gap that exists in the
biomedical workforce of the future. The IMP will address research training needs in the area of biological
membranes (biomembranes), which are crucially important structures that define and separate physical spaces
within and outside cells, making them fundamental to life on Earth. However, biomembranes do much more, as
they control intracellular signaling and development, are required for energy production, mediate drug delivery
and drug resistance, are essential for making essential cellular macromolecules, and affect growth and
movement, which impacts cancer and other diseases. Thus, understanding biomembranes impacts many critical
areas of biomedical research. Biomembranes research as a field covers the mechanisms by which membranes
are synthesized from their constituent proteins, lipids, and carbohydrates, are trafficked and changed in response
to the environment, and then in turn affect the many processes described above. Additionally, human
manipulation of natural and synthetic membranes can be harnessed for myriad applications from computation to
energy production to the development of new materials. Multiple fields and disciplines including biology, physics,
chemistry, engineering, and computational science have applicability to biomembranes, but increasingly, there
is a need for scientists who can bridge these fields and integrate different approaches to meet the next generation
of research challenges. The University of Tennessee, Knoxville (UT) has unique breadth and depth in
biomembrane research, with federally funded, collaborative researchers spanning 7 departments in 4 colleges.
The 32 faculty in the IMP mentor pool have a shared commitment to establish a training program that will span
fields and disciplines. These scientists are already working together through the establishment of the UT-
facilitated Community of Scholars (COS) for Biomembranes, which has met 2-3 times every semester since
2018, and where many students have presented seminars on their research. The shared research, training, and
overall momentum that exists within the Biomembranes COS forms the foundation for the IMP T32. Multiple
investigators within the Biomembranes COS have ongoing collaborations that span fields and disciplines, and
have co-mentored graduate students. The establishment of a T32-based IMP will formalize this integrated
approach to training so these students can advance fundamental knowledge of biomembranes and apply this
knowledge to improve human health. In addition to integrated training in science, the IMP will further enhance
training in responsible conduct of research, reproducibility, and diversity and inclusion, which are already being
addressed at UT, but will be formalized under this NIH T32 mechanism.

Public health relevance
Project Narrative Membranes are barriers of proteins, fats, and sugars that form the borders of all living cells on earth, and are essential to cellular viability; understanding how membranes function is crucial for many key areas of biomedicine including cancer, drug resistant infections, development, drug delivery, and energy production. However, future progress in membrane research requires that a new generation of scientists be trained who can combine approaches and concepts from many disparate fields such as physics, chemistry, biology, and computer science. The Integrated Membrane Program (IMP) training grant is especially designed to train scientists to integrate multiple approaches to address these next-generation challenges.